Velocity-Selective Arterial Spin Labeling based Perfusion Mapping for Alzheimer's disease

Project Abstract
Alzheimer's Disease (AD) is the leading cause of dementia in elderly population. Imaging biomarkers
have been established on PET with respective tracers for mapping accumulation of amyloid and tau, as well as
neurodegeneration. Furthermore, considerable overlap between cerebrovascular disease (CVD) and AD
suggest additive or synergistic effects of both pathologies on cognitive decline. Vascular dysfunction has also
been recognized as an important biomarker for better understanding and characterizing this multifactorial
disease. Reliable mapping of neurodegeneration and vascular dysfunction could play critical roles in many
clinical applications. Cerebral blood flow (CBF) is a fundamental hemodynamic parameter that characterizes
brain perfusion as both a surrogate of neuro function and a marker for small vessel disease. Arterial spin
labeling (ASL) perfusion MRI offers the great advantages of not requiring an exogenous contrast agent and
being free of ionizing radiation. Obtaining both structural MRI and perfusion MRI in a single visit to the clinic is
highly desirable for scanning the elderly subjects. Interpretation of CBF maps derived from spatially selective
ASL methods need to be cautious about the artificial perfusion deficit due to the slow flow often incurred in the
older subjects. Despite many efforts in this field, there remains to be an unmet and urgent need to establish
a standardized, reliable, and validated ASL-based CBF mapping protocol for multi-site across-vendor
neuroimaging studies for AD. Velocity-selective ASL (VSASL) derived CBF maps are ideally suited for
characterization of both neurodegeneration and vascular dysfunction among the elderly population, without
suffering the limitations presented by the slow flow. We have implemented the first velocity-selective inversion
(VSI) based VSASL with 3D acquisition on adult brains and demonstrated its higher sensitivity to perfusion
signal over conventional ASL methods. The proposed work capitalizes on the high perfusion sensitivity of VSI-
ASL recognized by the first guideline paper for VSASL, as well as accelerated acquisition and reconstruction
strategy, and represents its first AD application. The purpose of this study is to further optimize 3D VSI-ASL with
accelerated acquisition and reconstruction, and then ensure its multi-vendor compatibility (Aim 1); to evaluate
its reproducibility and validity between sessions, vendors, and modalities (Aim 2); to characterize VSI-ASL
derived CBF values of various brain regions in cognitively normal (CN) subjects, and patients with MCI and AD
through both cross-sectional and longitudinal comparisons (Aim 3). we will have demonstrated the optimized 3D
VSI-ASL technique with high reproducibility, validity, and sensitivity to detect changes in brain perfusion and
neurodegeneration, which can be readily utilized as a more practical and cost-effective imaging biomarker of
neurodegeneration and vascular dysfunction for multi-center and multi-vendor clinical studies of AD and ADRD.

Public health relevance
Project Narrative Alzheimer's Disease (AD) is the leading cause of dementia in elderly population. Cerebral blood flow is a fundamental hemodynamic parameter that characterizes both neurodegeneration and vascular dysfunction. This project proposes to demonstrated the optimized 3D velocity-selective arterial spin labeling technique with high reproducibility, validity, and sensitivity to detect changes in brain perfusion and neurodegeneration, which can be readily utilized as a more practical and cost-effective imaging biomarker for multi-center and multi-vendor clinical studies of AD and ADRD.